LIFETABLE ANALYSIS OF INTRAUTERINE INSEMINATION PREGNANCY RATES

Using a life table analysis, investigators are evaluating couples with cervical factor, male factor and idiopathic infertility. Uses CDMAS only.